Opioid Use Disorder and Residential Treatment in Medicaid

ABSTRACT
Carrie E. Fry PhD, MEd is an Assistant Professor in the Department of Health Policy in the Vanderbilt School of
Medicine. She is a health services and policy researcher whose portfolio is focused on improving health and
social outcomes for Americans with a substance use disorder (SUD) or mental illness through rigorous
observational and quasi-experimental methods. This training grant will support Dr. Fry’s career goal of becoming
an independent researcher with expertise in evaluation strategies to inform policy affecting marginalized
Americans. This type of expertise is in high demand: the incidence and prevalence of opioid use disorder (OUD)
has significantly increased since the mid-2010s with related harms, including emergency room visits and fatal
overdoses, increasing at a similar pace. Access to evidence-based OUD treatments, especially among Medicaid
enrollees, has not increased at the same rate. For these reasons, understanding the Medicaid policy levers to
increase access to treatment is crucial to combatting the broader SUD crises in the US. One way state Medicaid
programs have responded is by expanding the continuum of care to include residential treatment. Historically,
Medicaid programs not been allowed to provide residential SUD treatment for most adults. Following guidance
issued in 2015, states could apply for time-limited, demonstration waivers to expand coverage for residential
treatment to adults between 21-64 years old. Since then, 32 states have received approval for and implemented
a Section 1115 waiver to provide residential SUD treatment. States have flexibility regarding the specific
provisions of these waivers potentially leading to mixed outcomes, and the impact of expanded residential
treatment coverage in Medicaid is largely unknown. The research proposed in this K01 will address these gaps
to inform future policy. Aim 1 will survey Medicaid officials in the 13 states participating in the Medicaid Distributed
Research Network (MODRN) to identify variation in Medicaid residential treatment coverage. Then, I will conduct
semi-structured interviews with Medicaid and other state officials from six MODRN states to further explore these
differences. Aim 2 will use Medicaid claims data from three states to produce reliable and generalizable evidence
on the effect of expanded coverage for residential treatment on beneficiary-level health and utilization outcomes.
Details gleaned from these survey and interviews will be used to appropriately contextualize Aim 2’s results; the
evaluation proposed in Aim 2 can be completed regardless of these findings. Finally, Aim 3 will produce the first
generalizable estimates of co-morbid SUD among Medicaid enrollees with OUD, a subpopulation more likely to
access residential treatment. Results from these aims will provide extensive preliminary data for an R01
evaluating these coverage expansions among sub-populations identified in Aim 3 and inform future Medicaid
policy around residential treatment. With the assistance of her mentors, Dr. Fry has identified training objectives
in addiction medicine, state health policy, and measurement issues in administrative claims data that will further
her progress toward becoming a leading, independent researcher in the field of SUD and Medicaid policy.

Public health relevance
PROJECT NARRATIVE State and federal policymakers have expanded access to residential treatment for substance use disorder (SUD) in the Medicaid program, broadening access to the full continuum of care, increasing the capacity in the greater SUD treatment system, and potentially spurring patients to seek care for an SUD. This project will examine the relationship between increasing coverage for residential treatment services among Medicaid beneficiaries with opioid use disorder and explore the implications of co-morbid SUDs. Through the proposed research and training in this Mentored Research Scientist Career Development Award, I will gain the additional skills and knowledge to pursue innovative, independent research to improve access to care and health outcomes for people with SUD in the U.S.